MUCOSAL IMMUNE RESPONSE FOR CHRONIC IDIOPATHIC COLITIS BY TRICHURIS TRICHIURA

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The goal of this project is to study the mucosal and peripheral immune responses in rhesus macaques with naturally occurring chronic colitis to experimental infection with the parasitic helminth Trichuris trichuria.